A multidisciplinary approach to study ecotypes driving transmission and pathogenesis of Visceral Leishmaniasis (VL) and Post kala-azar dermal leishmaniasis (PKDL) in Eastern Africa

Abstract
Over 12 million people currently suffer from leishmaniasis, and ~2 million new cases occur each year, making it
a major global health problem and a WHO classified neglected tropical disease. Visceral leishmaniasis (VL) is a
life-threatening form of the disease caused by Leishmania donovani and Leishmania infantum and is
characterized by parasite dissemination to the liver, spleen and bone marrow. Second to malaria, VL causes
most deaths amongst parasitic diseases. The majority of VL cases caused by L. donovani are reported from
East Africa, particularly Kenya, Sudan, South Sudan and Ethiopia. In Sudan, 40-50% of treated VL patients
develop post kala azar dermal leishmaniasis (PKDL) which is characterized by proliferation of parasites in the
skin leading to macular or nodular dermal lesions. PKDL self-resolves in the majority, but up to 20% of cases
become chronic and non-healing. PKDL lesions have recently been implicated as a source of infection in sand
flies. VL in eastern Africa is an epidemiologically and clinically diverse disease. in In East Africa, two distinct
ecotypes of VL, the northern ecotype (NE-VL) in Northern Ethiopia and eastern Sudan and the southern ecotype
(SE-VL) in southern Ethiopia, Kenya, Uganda and Somalia, have been identified based on genetic differences
in parasites, and different sand fly vector species and ecological features. Phlebotomus martini (southern
ecotype) have a micro-ecological preference for termite mounds (breeding /resting site); and P. orientalis
(northern ecotype) depends on black cotton soil cracks. The disease phenotype and clinical outcomes also vary
between the two ecotypes and within the northern ecotype. For example, PKDL is common in NE-VL but rare in
SE-VL. Furthermore, although north Ethiopia and Sudan have genotypically similar parasites, PKDL is common
in Sudan but rare in north Ethiopia. Likewise, there are differences in the therapeutic response to paramomycin
and liposomal amphotericin as NE-VL responds poorly to treatment compared to SE-VL. Unlike Asia, VL in East
Africa is targeted for control rather than elimination by WHO, partly due to significant knowledge gaps in
ecoepidemiology, vector biology, and host and parasite factors driving transmission and pathogenesis. VL
transmission is influenced by intrinsic factors such as vector competence, longevity and gut microbiota, and
extrinsic factors including reservoir diversity, vector feeding preferences, and vector anthropophilicity, among
others. Yet, how these factors promote VL transmission in Eastern Africa and elsewhere is poorly understood.
To address these knowledge gaps, in this U01 project we propose to study the eco-epidemiology of VL at 4 sites
in East Africa which are endemic for SE-VL (2 sites) or NE-VL (2 sites) and have different ecological and
transmission features (Aim 1), determine the relative significance of factors that influence vector behavior and
ecology as drivers of transmission (Aim 2), and identify host and parasite determinants of pathogenesis in VL
and PKDL (Aim3). Collectively, our studies will contribute to VL knowledge landscape, control and
innovation opportunities and discovery of new treatments towards VL and PKDL elimination in East Africa.

Public health relevance
Project Narrative Visceral leishmaniasis (VL) is a neglected tropical disease which is fatal if left untreated. Majority of VL cases in the world are reported from Eastern Africa, particularly Ethiopia, Sudan, and Kenya. The goal of this project is to study the risk factors that are associated with transmission of this infection in these high endemic countries, understand the ecology and behavior of sand flies which transmit this disease and identify potential host and parasite factors responsible for disease progression and pathogenesis. These studies will provide critical data required for developing control and prevention strategies for elimination of VL from Eastern Africa.